EVALUATION OF RENAL TRANSPLANT CANDIDATES USING ADENOSINE THALLIUM SCINTIGRAPHY

The objective of this study is to investigate the coronary physiology of patients with end-stage renal disease who are undergoing evaluation for renal transplantation. The following hypotheses will be investigated: 1) the epicardial coronary arteries in patients with chronic renal failure will exhibit defective edothelium-dependent vasodilation; 2) the coronary microcirculation in patients with chronic renal failure will exhibit defective endothelium-dependent vasodilation.